A viral vector-based vaccine to induce humoral and cellular immune protection against Powassan virus in a tick transmission model

ABSTRACT
We aim to develop a safe and effective vaccine that provides robust protection against Powassan virus
(POWV). Our working hypothesis is that the safe and effective induction of both branches of the adaptive
immune response are critical to counteract Flavivirus infections such as POWV; this includes the humoral
(neutralizing antibody) response that prevents virus dissemination into the host, and T cell mediated
responses that appear to be required for early containment of the pathogen. Accordingly, our vaccine
design is based on the modified vaccinia Ankara vector (MVA), a vaccine platform used in humans that is
well characterized for its safety and the stimulation of both humoral and cellular immune responses. Our
vaccine design incorporates the surface proteins E and prM that are known to induce neutralizing
antibodies as a prM-E construct, and adds the non-structural 1 protein (NSl), known to activate the host
cellular immune mechanisms against the Flaviviridae family. Using this vaccine design, we will test the
hypothesis that simultaneous engagement of the humoral and cellular immune mechanisms provides
optimal protection from POWV infection in mice.

Public health relevance
NARRATIVE Powassan virus (POWV) is an emerging neurotropic arbovirus spread by lxodes scapularis ticks that causes encephalitis in the infected host. Up to 5% of deer ticks in the United States now test positive for POWV. Powassan virus encephalitis is associated with considerable mortality and poses a risk of long-term neurological complications. The development of such a vaccine is of utmost importance to respond to this emerging public health threat.